NOVEL TARGETS IN A DRUG DEVELOPMENT PROGRAM

Resistance to antibiotics by Gram-positive bacteria has presented the pharmaceutical industry with the challenge of developing a new chemical class of antibacterial drugs. Cubist Pharmaceuticals has addressed this challenge with a target-based approach to drug discovery. Cubist's philosophy is to utilize novel, essential targets in high throughput screening programs to identify potential drug candidates. Here we propose a high throughput screening program to identify small molecule chemical inhibitors of a target essential to Staphylococcus aureus. We present experimentation that will allow the acquisition and characterization of the target, the identification of chemical inhibitors via high throughput screening and a thorough analysis of these inhibitors to determine in vitro and in vivo mechanisms of action. Phase II of this project will involve the optimization of these inhibitors to drug candidate status. PROPOSED COMMERCIAL APPLICATIONS: The commercial applicability of this project lies in the recent emergence of drug-resistant Gram-positive bacteria and the ensuing need for a new chemical class of antibiotics. One approach to the discovery of novel antibiotics is to identify inhibitors of proteins that are essential for cell viability. In this proposal we outline a research project that will allow us to identify inhibitors of essential enzymes. Such inhibitors will then serve as leads for the development of new antibacterial drugs.